Pre-Doctoral Pharmacology Training Program

Project Summary
The objective of the Yale Predoctoral Pharmacology Training Program (PPTP) is to train an outstanding and
diverse group of graduate students in the pharmacological sciences for research careers in academia, the
pharmaceutical and biotechnology industries, or government. The PPTP will accomplish this objective by
drawing on the experiences and strengths learned from our previous 45 year-long training program. Our
innovative and interdisciplinary curriculum will integrate fundamental pharmacological principles with related
areas of modern biological science, including signal transduction, metabolism, neuroscience, and structural
biology. Classroom activities in core topics will be complemented with a newly developed course in drug
discovery and development that offers hands-on experience in high-throughput screening, proteomics, and
functional genomics, as well as interactive workshops conducted by leaders in the pharmaceutical industry. A
group of 47 world-class faculty have been assembled from multiple departments, all of whom are dedicated to
mentoring and providing a safe and inclusive environment for their trainees. Our mentors will train students in
laboratory-based research meeting the highest standards of rigor, reproducibility and ethics. Outside of the
laboratory, students will participate in activities to acquire essential skills, including two semesters of teaching
and monthly research-in-progress talks. We will promote a cohesive and inclusive PPTP community through
regular activities including an annual symposium and retreat, a career development series featuring program
alumni, town hall meetings, student organized “research chats”, and a seminar series drawing from leading
scientists in pharmacology and related disciplines. Student progress will be assessed through a qualifying
examination administered during their second year, and through regular thesis committee meetings occurring
through the remainder of their doctoral training. Student feedback will be fully integrated into the delivery of the
PPTP training experience in order to optimize program outcomes and to guide future improvements. Additionally,
we have developed special assessment tools and surveys that monitor trainee development, which will be
augmented by tracking trainee outcomes. The PPTP is unique among T32-supported programs at Yale as it is
the only one that provides training in core principles of pharmacology. Experiences provided by our program will
equip students for successful careers in biomedicine, meeting a national need for well-trained individuals with
expertise in the pharmacological sciences. We request 8 training positions to appoint 4 second year and 4 third
year students per year.

Public health relevance
Project Narrative The Pre-Doctoral Pharmacology Training Program (PPTP) at Yale University will provide rigorous, advanced training in the pharmacological sciences by employing innovative teaching methodologies and cutting-edge technologies. The PPTP will prepare students for research and research-related careers in academia, industry, and the non-profit sector.